Understanding and Targeting Transcriptional Master Regulators in Hepatocellular Carcinoma

Hepatocellular carcinoma (HCC) causes nearly 800,000 deaths worldwide and represents one of the fastest-
rising tumors in the US. Despite recent FDA approval of combination therapies for HCC, the majority of patients
die within two years. A major challenge in this context is the high genetic diversity of HCC and its low degree of
actionable mutations. Accordingly, the most effective therapies, such as atezolizumab + bevacizumab, target the
immune and tumor microenvironment (TME) but not tumor cells. Tyrosine kinase inhibitors (TKI) such as sorafenib
and lenvatinib target growth factor signaling cascades in tumor cells but exert only moderate effects on survival.
In addition, the effects of TKI may also be mediated via the TME, and current data suggest that combinations of
TKI and immune checkpoint inhibitor (ICI) therapy do not synergize. This suggests that current combination
therapies have reached a plateau, leaving direct tumor cell targeting and potentially synergistic combinations of
tumor cell plus TME targeting a largely unexplored therapeutic gap. Here, we seek to address this gap by
functionally characterizing the transcriptional regulatory landscape of HCC with the goal of uncovering novel
tumor cell-intrinsic vulnerabilities. Tumor cells are characterized by aberrant “cancer transcriptomes”, in which
specific modules are critical for the maintenance of the cancer state and its hallmarks, such as high proliferation
and altered metabolism. Transcriptional master regulators (TMR) represent key nodes within these
transcriptomic networks, and about 20-30% of TMR are essential for tumor cells, representing targetable
“bottlenecks”. As TMR often operate independently of upstream driver mutations, they are shared by a wider
range of patients and represent attractive targets in tumors with diverse mutational profiles such as HCC. Based
on promising preliminary data, we seek to computationally establish human HCC TMR from two large patient
cohorts, confirm their tumor cell specificity by single-cell RNA-seq-based analyses, and correlate TMR with
clinical parameters and outcomes (Aim 1). Next, we seek to validate tumor cell-intrinsic functions of novel
activated and repressed TMR, that are shared with our human cohorts and associated with patient survival; for
this, we will use CRISPR interference (CRISPRi) and CRISPR activation (CRISPRa) in vivo screens and
subsequent validation of the top hits by testing their effects on tumor growth via single gene CRISPRi or CRISPRa
(Aim 2). Finally, we will therapeutically target tumor cell TMR; and screen and test combination therapy with ICI
and VEGF inhibition to evaluate synergies between tumor cell TMR- and TME-targeted therapies (Aim 3). The
proposed multidimensional research plan will be realized by a strong multi-disciplinary team (Schwabe, Wangen-
steen, Zucman-Rossi, Califano) with a history of collaboration and a synergistic and unique combination of
expertise in HCC cohorts, HCC biology, computational biology and in vivo CRISPR. The proposed studies will not
only provide deeper understanding of transcriptional regulation in HCC but will also reveal novel tumor-intrinsic
candidates for tumor cell-based mono- and combination therapy, and thereby advance therapeutic concepts.

Public health relevance
Hepatocellular carcinoma (HCC) is the most common type of liver cancer and the third leading cause of cancer mortality world-wide. The majority of patients with advanced HCC still die within two years and the most effective therapies target non-tumor cells rather than tumor cells themselves. Our proposal seeks to close this gap by characterizing factors that are essential for the function of liver cancer cells, called “transcriptional master regulators”, with the goal to establish these as novel therapeutic targets in HCC tumor cells.